Signal Integration During Eye Formation

Project Summary:

A long-­standing question in biology is how cells respond to multiple signaling inputs with a specific response.
This proposal investigates the intersections of Notch and Hh signaling pathways, which are widely required
during development, and basic mechanisms congenital eye disease. Both signaling systems regulate cell
proliferation, morphogenesis, cell polarity, differentiation, apoptosis and stem cell maintenance. However, the
spatiotemporal contexts for each differs at the cellular and tissue levels during optic vesicle morphogenesis
and growth. This proposal will use in vivo complex conditional (cre-­lox) mouse genetics, mouse transgenics,
embryology, iPSC-­derived retinal organoids, histology, immunohistochemistry, confocal microscopy, in situ
hybridization, qPCR and bioinformatics technologies to investigate basic, mechanistic questions about the
initiation and progression of eye formation from the embryonic brain. We will address several important
questions: 1) What are the spatial and temporal constraints for Notch versus Hh in controlling growth,
morphogenesis, patterning, tissue polarity and the timing of differentiation in the optic vesicle, optic cup, RPE
and optic stalk? 3) What are the optimal conditions by which Notch and Shh pathways contribute to the
generation of retinal ganglion cell and cone photoreceptor neurons in retinal organoid culture? 1) How do the
Notch and Hh pathways regulate the eye expression domains of a common target gene, Hes1?

Public health relevance
Project Narrative: This research will provide fundamental understanding of optic vesicle outgrowth from the ventral thalamus and morphogenesis into the optic cup, RPE and stalk. Such information ultimately informs the pathogenesis and/or treatment of congenital diseases like anophthalmia, microphthalmia, coloboma, cyclopia, septo- optic dysplasia or optic nerve hypoplasia. This study will create new transgenic and mutant mouse models and provide new insights into retinal stem cell biology, two overt goals of the National Eye Institute. Moreover, mechanistic information about the Notch and Hh signaling pathways will be gained, with broad implications for developmental, stem cell and cancer biology.